Cervix monitor for risk assessment of spontaneous preterm delivery

Project Summary
Preterm birth is a leading cause of infant mortality and morbidity, with an estimated 13.4 million babies born
preterm in 2020. The rate of preterm birth varies across countries, ranging from 4% to 16%. Notably, preterm
birth now represents the leading cause of death among children under 5 years of age. Preterm birth ranks among
the most complex and pressing challenges in obstetrics. Most preterm births occur spontaneously, making the
identification of women at risk for spontaneous preterm birth (sPTB) a paramount issue. Premature softening,
shortening, and dilation of the cervix, which may be considered early mechanical failure, is associated with
preterm birth. Clinical findings support the hypothesis that cervical elastography may provide effective
biomarkers for predicting preterm delivery. However, in current clinical practice, the progress of cervical ripening
is often monitored subjectively through visual inspection and digital examination. The digital cervical score and
Bishop score, while used as predictors of sPTB, show relatively low diagnostic accuracy, ranging from 61% to
68%. Despite numerous risk factors associated with sPTB having been identified in previous decades, the ability
to accurately predict when spontaneous labor will occur remains elusive. That is why the validation of novel
biomarkers, which could identify conditions leading to sPTB with a high level of confidence, is so important. In
Phases I and II of the research, a novel, cost-effective technique was developed and tested in feasibility and
development clinical studies. Receiver operating characteristic analysis revealed that cervical elasticity,
expressed as the stress-to-strain ratio, had 95.0% accuracy (95% CI, 88.5–100.0) for predicting sPTB. The
developed probe, integrating four tactile and a single ultrasound transducer, demonstrated potential in predicting
sPTB cost-effectively. The primary aim of Phase IIB is to conduct a clinical validation study on 750 pregnant
women, collecting data at the end of the second trimester using the updated pre-production Cervix Monitor
device. This data will facilitate two separate FDA submissions: one for a measurement claim and another for a
diagnostic claim. The overarching objective of this project is to introduce a compact, cost-effective, and user-
friendly device into clinical practice, designed for the detection of conditions leading to sPTB.

Public health relevance
Project Narrative The project addresses the critical challenge of identifying women at risk for spontaneous preterm birth, a leading cause of infant mortality and health complications globally. It focuses on improving diagnostic accuracy through cervical elastography, employing a specialized probe in a clinical study involving 750 pregnant women, to develop a portable, user-friendly Cervix Monitor device. This research aims to gather data for FDA submissions and create a tool for accurately measuring cervical changes and assessing risk of spontaneous preterm birth, addressing the limitations of current methods.